MATERIALS SCIENCE

The biomedical engineering Ph.D. program does not begin the formal research leading to the degree until the second year of study. The first year is heavily invested in coursework. I have not committed firmly to a research project, other than to say it will involve dental implants. I am now investigating the potential for research in the area of calcium phosphate coatings with titanium root form implants, particularly in the area of crystallinity state, solubility, and adherence. I anticipate my research sponsor will be Dr. Linda Lucas, Associate Professor of Biomedical Engineering.